Extracellular vesicles encapsulating CRISPR machinery for treatment of SARS-CoV-2 infection

Summary/Abstract
SARS-CoV-2 has caused the deaths of millions of people globally. Effective antiviral therapeutic
treatment options are urgently needed. CRISPR-mediated genome editing has provided a very promising avenue
for treatment of a variety of genetic diseases. Particularly, the CRISPR-Cas13 system has been demonstrated
to possess the potential of inhibiting SARS-CoV-2 and influenza infections by degradation of viral genomic RNA
and viral mRNA. However, it is still very challenging to deliver the CRISPR machinery to initiate genome editing
efficiently in vivo. Extracellular vesicles (EVs) contain a variety of molecular components including lipids, mRNA,
microRNAs, and proteins. A large body of studies has shown that EVs mediate cell-to-cell communication by
transmitting their encapsulated contents. This proposal intends to construct EVs encapsulating the CRISPR
machinery and deliver the EVs to respiratory epithelial cells to inhibit SARS-CoV-2 proliferation in vivo. We will
therefore genetically engineer the Cas13d protein so that Cas13d/CRISPR-RNA (crRNA) ribonucleoprotein
complex can be encapsulated into EVs. We will also engineer the membrane of EVs, such that EVs target
respiratory epithelial cells and deliver Cas13d/crRNA for inhibiting SARS-CoV-2 viral assembly and proliferation,
thereby inhibiting COVID-19. This study will allow us to understand the feasibility of an EVs-based vehicle to
deliver genome editing machinery to inhibit SARS-CoV-2 proliferation in lung epithelial cells. This study will
provide a treatment option for COVID-19 patients to reduce disease severity and mortality.

Public health relevance
Project Narrative Myristoylation facilitates proteins’ association with the cell membrane, and their encapsulation into extracellular vesicles. This project will produce extracellular vesicles encapsulating Cas13d/crRNA ribonucleoprotein by Cas13d myristoylation and incorporating the spike protein into the EVs membrane to confer transfection specificity to target SARS-CoV-2 infected respiratory epithelial cells. The generated extracellular vesicles will provide an avenue for the treatment of COVID-19.